Genetic methods for studying Gardnerella virulence

PROJECT SUMMARY
Bacterial vaginosis (BV) occurs in nearly one third of women of reproductive age, causing significant problems
for sexual and reproductive health. Women with BV are predisposed to pregnancy complications including
amnionitis and preterm delivery. Gardnerella spp. are major players in the BV dysbiosis, displacing
Lactobacillus spp. and forming a robust biofilm supporting the growth of multiple anaerobes. The biofilm also
serves as the infectious form for transmitting bacterial vaginosis between people. Gardnerella make a number
of putative virulence factors including multiple pili, lipases, sialidases, and the pore-forming toxin vaginolysin. It
has been difficult to study Gardnerella virulence factors due to the inability to make targeted mutations or
introduce genetic constructs. We discovered a way to make targeted insertion mutations using suicide
plasmids in Gardnerella spp., and we propose to further develop these methods to produce a full set of tools
for Gardnerella genetic manipulation. First, we will improve methods for making insertional mutants by
determining factors affecting transformation frequency and insert stability, and by developing use of a counter-
selectable marker to allow for creation of selectable unmarked mutations such as deletions and point
mutations. Furthermore, we will test different methods of insert replacement to optimize creation of unmarked
mutations. Second, we will develop methods and constructs for gene expression from the Gardnerella
chromosome in order to produce constitutive or regulated complement gene expression, transcriptional fusions
to Gardnerella ‘lacZ, or translational fusions to the FLAG epitope. The usefulness of the methods will be tested
with mutations in the vaginolysin gene.

Public health relevance
PROJECT NARRATIVE Bacterial vaginosis is the most common gynecological disease in women of reproductive age and causes pregnancy complications including infection of the amniotic sac and preterm birth. Research on the most common bacterial species associated with bacterial vaginosis, Gardnerella spp., has been hampered due to the inability to make genetic mutations in these bacteria. We have discovered a way to make genetic mutations in Gardnerella spp., and the proposed studies would capitalize on this discovery by developing tools for making gene deletions, insertions, and single base changes as well as making gene constructs for studying gene expression and protein production and localization.